Novel approaches for cardiac reprogramming: Exosome delivery of reprogramming miRNAs and repressor targeting siRNAs

In situ reprogramming of scar fibroblasts into cardiomyocytes is therapeutically beneficial. However, functional
improvements are relatively modest. The challenges for effective reprogramming are suboptimal timing of
delivery, repressive barriers, and poor delivery to fibroblasts. Consequently, we hypothesize reprogramming
efficacy will be improved by delivering reprogramming factors into the heart once the infarct has stabilized
ablating the function of a repressor complex, and targeting reprogramming factors to cardiac fibroblasts. The
hypothesis will be tested by three specific aims. Aim 1 will focus on the mechanism by which a repressor complex
comprised of Cbx1, PurB and Sp3 inhibits cardiomyocyte genes. Studies will test the hypothesis that the
repressor complex functions by inducing a DNA-loop and blocking access to enhancer elements. DNA-looping
will be investigated by deleting or repositioning the repressor complex binding sites through the introduction of
variable helical twists in a promoter reporter construct and then measuring luciferase reporter activity. Due to the
apparent cooperativity between Cbx1, PurB and Sp3, we will also determine if knockdown of one repressor is
sufficient to re-capitulate the effects of combined knockdown. Aim 2 will investigate the hypothesis that targeting
the Cbx1-PurB-Sp3 repressor complex will improve miR combo efficacy in a mouse model of cardiac injury. The
hypothesis will be tested by injecting fibroblast-selective C166-derived exosomes containing miR combo and a
repressor-complex targeting siRNA into the hearts of fibroblast-lineage tracing mice immediately following MI or
up to 4 weeks post infarct. The latter time-point will be used to determine if reprogramming can be employed as
a salvage therapy once the infarct is completed with development of fibrosis. The effects on reprogramming
(lineage tracing), cardiac structure (infarct size, fibrosis, etc.) and cardiac function (echocardiography) will be
assessed over time. Aim 3 is tasked with moving reprogramming towards clinical applications via studies in a
pre-clinical pig model of cardiac injury. Our preliminary data shows that pig cardiac fibroblasts internalize C166-
derived exosomes and that miR combo improved cardiac function in infarcted Yorkshire mini-pigs. Following
transient occlusion, C166-derived exosomes loaded with FITC-labelled miRNAs will be delivered into the hearts
of Yorkshire mini-pigs and cardiac tissue analyzed for exosome uptake by measuring FITC incorporation in
cardiac cells including fibroblasts, cardiomyocytes and endothelial cells. Additional studies will determine the
function benefits arising from a therapy combining miR combo and a repressor targeting siRNA. In summary,
successful completion of these studies is expected to delineate the role of transcription repressors as a newly
discovered barrier to reprogramming. In addition, applying this knowledge in conjunction with fibroblast-selective
delivery of miR combo via C166-derived exosomes is expected to enhance the efficacy and therapeutic
outcomes of reprogramming fibroblasts to cardiomyocytes. Moreover, translational studies will move our MI-
therapy closer to clinical applications.

Public health relevance
RELEVANCE STATEMENT We have shown that fibroblasts in the scar tissue can be reprogrammed into cardiomyocytes through a combination of miRNAs called miR combo (miR-1, miR-133a, miR-208a, and miR-499- 5p). To improve the efficacy of reprogramming, we propose to combine depletion of these repressors with fibroblast delivery of our miR combo via a fibroblast-selective exosome. Furthermore, we propose to carry out pre-clinical studies in the pig.